Nanoparticulate Coatings Enhance Ion Detection

(Project Summary Changes 7/3/2023 for Equipment Supplement in bold) Ionwerks' phase II has been
the catalyst by which Hamamatsu USA (Sommerville NJ) has become interested in our project and in
our interaction with Rutgers University (New Brunswick NJ). In a joint meeting at Rutgers (Dec 2022)
Hamamatsu made us aware of two of their new commercially released remarkable innovations: 1) A
silicon based Avalanche Particle Detector (APD) which has unit sensitivity and subnanosecond pulse
response to >1KeV electrons. 2) Hamamatsu's new Borosilicate MCPs coated with MgO SE emissive
thin films which outperforms conventional Pb glass MCP in every way: orders of magnitude longer
lifetime, higher gain --which improves with ion dose--, and a constant picosecond time response
maintained at the higher gain and long lifetimes. Hamamatsu offers both for sale internationally.
Addition of our Nanoparticulate thin films during our existing phase II could likely improve
either of these products. However, we do not have electronics which can measure changes in
picosecond pulsed timing performance and gain increase (or degradation) on the sub-nanosecond
time scale. Thus the opportunity to acquire an advanced oscilloscope which would measure these
parameters could not come at a more perfect time. Our previously described goals of the parent phase
II application remain unaltered as follows. Ionwerks new thin film deposition technique for increasing the
gain and sensitivity of existing microchannel ion detectors was proven in a previously completed NIH phase I.
An increased Secondary Electron (SE) yield from these films was found to improve with ion doses of helium up
to > 100 Coulombs/cm2 while the electron yield from the uncoated detector first surface decreased after 1
Coulombs/cm2. A NIH Phase II is using these films to vary elemental composition and morphology of the first
surface to increase the first hit SE yield and to prolong the deposited layer lifetime. Detector testing will
proceed with in-house ion and electron sources. Methods for putting these thin film coatings onto the sidewalls
of the MCP (in addition to covering the front detector surface) should increase the detector gain and
substantially prolong the MCP detector lifetime. We will emphasize the use of the Zeiss Orion helium ion
microscope at Rutgers to perform accelerated lifetime testing of the MCP pulse height, gain and first surface
secondary electron yield from individual pores. Elemental composition change in the first hit area of the
microchannel pore will also be determined by Nanoscale Rutherford backscattering within the Orion and will be
correlated with the lifetime and yield measurement. The combination of the Zeiss Orion helium ion microscope
configured with the Ionwerks NanoRBS spectrometer should prove to be a crucial tool in detector physics. In
addition the overall performance of the NanoRBS will improve when this spectrometer is retrofitted with newly
enhanced MCPs combined with new APDs from this phase II effort.

Public health relevance
As a supplement to the existing parent Phase II project, we need to acquire an advanced 1.5‐3 GHz multichannel oscilloscope with sufficient memory for testing improved detectors and also to acquire enhanced imaging data from detectors within the Helium Ion Microscope at Rutgers University. The 100 picosecond resolution timing capability of the scope will allow ultimate testing of our improved detectors. As part of our Phase II we are working with Rutgers and Hamamatsu to compare the performance of our improved Pb based MCPs (and also MCPs in general) against the recently released Hamamatsu solid state avalanche particle detectors (APD) for electron and fast particle detection. These APD solid state detectors now compete and are superior in time performance to subnanosecond MCP detectors. In addition the APDs give a good measure of the particle energy which is impossible to obtain with the MCP.